CXCR3-Mediated Cell-Cell Communication in Glaucoma

CXCR3-mediated Cell-Cell Communication in Glaucoma
SUMMARY
Glaucoma, which is characterized as progressive retinal ganglion cell (RGC) death and optic nerve
degeneration, is the second leading cause of irreversible blindness worldwide. Increased intraocular pressure
(IOP) is a main risk factor for glaucoma and is the only target for therapeutic intervention. However, lowering
IOP does not always stop the disease progression. There is an unmet need to understand the mechanisms of
neurodegeneration in glaucoma and identify novel targets for glaucoma therapy. Cell-cell communication plays
a key role in pathophysiological changes in multicellular organisms. Chemokines are a family of structurally
related pro-inflammatory peptides that plays a central role in the communication between injured/infected cells
and other cell types via binding to specific chemokine receptors on the membrane of their respective target
cells. While it has been well appreciated that chemokines are critically involved in the pathogenesis of
inflammatory, autoimmune, infectious, oncologic, cardiovascular and neurodegenerative diseases, the role of
retina-derived chemokines in glaucomatous optic neuropathy is largely unknown. CXCL10 is a chemokine and
its receptor is CXCR3. This pathway has a key role in inflammation by recruiting and activating several types of
leukocytes including macrophage/microglia and T cells. In this project, we hypothesize that the
CXCL10/CXCR3 pathway has an essential role in the communication between RGCs and other cell types
(immune cells and astrocytes) during glaucoma and blocking this pathway alleviates dysfunction/degeneration
of RGCs and their axons. We propose the following three aims: (Aim1) Test the hypothesis that CXCR3
signaling plays a key role in the communication between RGCs and immune cells, which contributes to
glaucomatous optic neuropathy; (Aim2) Test the hypothesis that CXCR3 induces toxic RGC-astrocyte
crosstalk via CXCR3-mediated C3/C3aR signaling; (Aim3) Test the hypothesis that blocking CXCR3 is an
effective approach to treat glaucoma. We will integrate a series of novel methodologies in the studies, such as
bone marrow chimeric mice, CXCR3 conditional knockout mice, AAV2-mediated gene therapy, real-time
imaging of leukocyte trafficking, tissue optical clearing, and clinic-relevant non-invasive imaging and functional
tests. Taken together, our proposed study will provide important new knowledge on CXCL10/CXCR3-mediated
cell-cell communication in neurodegeneration and may identify the novel therapeutic approaches to manage
glaucomatous optic neuropathy. This proposal is in line with “Research Needs, Gaps, and Opportunities”
identified in the NEI Strategic Plan: 1) The role of non-neuronal cells such as glia is critical for understanding
degenerative diseases; 2) Investigate neurobiology roles for immune factors that challenge orthodoxy and
examine whether these “immune” factors are playing nontraditional roles for vision function; 3) Identify targeted
therapeutics or non-steroidal anti-inflammatory drugs for immune-related diseases.

Public health relevance
NARRATIVE Chemokine CXCL10 and its receptor CXCR3 are involved in the pathogenesis of many inflammatory diseases. Our proposed studies aim to understand the pathophysiological role of CXCL10/CXCR3 in cell-cell communication in glaucoma. This proposed research may identify new therapeutic strategies for glaucoma treatment.